Animal Research Support

Marshall Nirenberg[unreadable] Robert Kotin [unreadable] Jay Chung [unreadable] Cecilia Lo [unreadable] Robert Adelstein[unreadable] Ken Kramer[unreadable] Neil Epstein [unreadable] Chengyu Liu[unreadable] Matt Daniels[unreadable] Stasia Anderson[unreadable] Rodney Levine[unreadable] Lois Greene[unreadable] John Hammer[unreadable] James Sellers[unreadable] Mark Knepper[unreadable] Maurice Burg [unreadable] Herb Geller[unreadable] Claire Waterman[unreadable] Michael Beaven[unreadable] Warren Leonard [unreadable] Keji Zhao[unreadable] Lance Pohl[unreadable] Rick Childs[unreadable] PI's supported include:[unreadable] [unreadable] Cynthia Dunbar[unreadable] Neal Young [unreadable] Robert Donahue[unreadable] Toren Finkel [unreadable] Robert Lederman[unreadable] Paul Hwang[unreadable] Michael Sack[unreadable] Manfred Boehm[unreadable] Andrew Arai[unreadable] Robert Balaban[unreadable] Han Wen[unreadable] Joel Moss[unreadable] Vince Manganiello[unreadable] Martha Vaughan[unreadable] Stewart Levine [unreadable] Alan Remaley[unreadable] Tish Murphy